KC Donnelly Externship Admin Supplement for Victoria Klaus P42ES007380 UKSRC

KC Donnelly for Victoria Klaus P42ES007380‐25 PD/PI: Kelly Pennell
KCD Project Description (abstract):
My current research within UKSRC Project 3 is to synthesize advanced sorbent materials with an affinity
for PFAS. These materials are currently being studied for their ability to remove PFAS from aqueous
systems, but we plan to assess their efficacy as enterosorbents to remove these contaminants from the
human body. PFAS have been connected to a series of adverse health effects, and one of the most
common routes of PFAS exposure is through contaminated drinking water. Thus, the removal of these
contaminants from both drinking water and the human body is needed. Enterosorbents are orally
administered sorbents that pass through the GI tract where they bind various substances without
disturbing other systems within the body prior to excretion. Importantly, enterosorbents have been
shown to be a promising, non‐invasive therapeutic treatment approach for acute and chronic impacts of
chemical contaminant exposures. Together with TAMUSRC Project 5 and their established bioassay
techniques and ecotoxicological analyses, we will analyze advanced sorbent materials developed at
UKSRC for treatment of PFAS in water at TAMUSRC to determine their safety and efficacy as
enterosorbents. Our advanced sorbents developed within UKSRC Project 3 will be screened to identify
those that exhibit the highest affinity for PFAS in preliminary aqueous studies at UK. These will be
analyzed for their enterosorbents applications using analytical technologies and bioassay methods as
part of TAMUSRC Project 5.

Public health relevance
KC Donnelly for Victoria Klaus P42ES007380‐25 PD/PI: Kelly Pennell Project Narrative The proposed research project that I would be performing during the KC Donnelly (KCD) externship would be focusing on the analysis of UKSRC-developed candidate advanced sorbent materials and determining their feasibility as enterosorbents to remove per- and polyfluoroalkyl substances (PFAS) from the GI Tract. While at Texas A&M, I will conduct ecotoxicological analyses using a series of living organism assays established as part of TAMUSRC to determine the toxicity and detoxification potential of UKSRC-developed advanced sorbent materials. This KCD will initiate a collaboration between the UKSRC and TAMUSRC and expects to increase the impacts of both centers.